RHU IL-10 (SCH52000) IN PATIENTS WITH MILD/MODERATE ULCERATIVE COLITIS

The purpose of this study is to study the efficacy, safety and tolerance of multiple doses of subcutaneous SCH 52000 in patients with mild to moderate ulcerative colitis.